Optimizing Pharmacotherapy with Noninvasive Wearable Sensors and Subscalp EEG

Project Summary
The apparently random nature of seizures is one of the most significant factors affecting quality of life for patients
with epilepsy. Accurate seizure forecasting could be transformative for patients with epilepsy, allowing patients
to modify activities to avoid risk, take fast-acting medications to stop seizures before they develop, and provide
a sense of empowerment over their disease. Successful seizure prediction has now been established using
ambulatory intracranial EEG devices. Unfortunately, no such device is currently available to patients, as no
commercial vendor has been successful to date at obtaining approval for clinical use of such a device.
Furthermore, invasive intracranial implants may not be appropriate for or acceptable to many patients given the
associated risk of infection and hemorrhage. Subscalp EEG recording has recently emerged as a viable means
for long-term monitoring of patients with epilepsy. A device is commercially available in the EU, but does not
yet have FDA clearance in the US. Recently published studies show the device to be reliable and robust, and
recordings longer than 6 months have been reported. In addition cycles of seizure risk have been identified in
wearable device physiological signals, and these long-term cycles may be capable of contributing to the
accuracy of seizure forecasts. This project will develop the ability to prospectively forecast seizures from
simultaneous subscalp EEG and wrist-worn wearable signals, and will assess the safety and feasibility of
administering a fast-acting supplemental medication with seizure forecasts to prevent seizures.

Public health relevance
Project Narrative In this project we take advantage of the UNEEG SubQ device for chronic subscalp EEG recording with distributed local and cloud analytics, telemetric data streaming, and patient-physician interface. This innovative distributed monitoring system will be used to detect electrophysiological and behavioral biomarkers impending seizures to guide self-administration of fast-acting medications. Our goal is to develop within the existing seizure management system a novel, targeted treatment method for epilepsy.